Sensing intracranial bioimpedance through anatomic windows for classifying stroke type

ABSTRACT
“Time lost is brain lost - every minute counts” – according to the Center for Disease Control (CDC) in reference
to strokes. Stroke is the 5th leading cause of death in the United States, 2nd in the world and will cost the U.S.
$183 billion annually by 2030. Every year 800,000 people will suffer a stroke in the U.S. alone and this high
incidence contributes to stroke being a leading cause of serious, long-term disability in the US. There are two
primary types of stroke: ischemic and hemorrhagic. Ischemic stroke involves blood or fatty plaque blocking a
vessel of the brain while hemorrhagic is defined by a vessel rupture or brain bleed. Each type requires
significantly different treatments, and treatment of the wrong type could have lethal consequences. This makes
stroke type identification crucial to receiving treatment. Thus, neurologic monitoring and timely intervention are
key for acute stroke recovery, yet currently no bedside monitor capable of detecting a recurrent stroke,
hemorrhagic transformation and/or evolving stroke at onset exists. Today’s standard-of-care relies on monitoring
general patient vitals and periodic CT/MRI scans to image the intracranial state; unfortunately, the large time
periods between scans delays possible detection of a high-consequence change in condition. With every minute
of pre-intervention time equating to an increase in lasting disability odds, a real-time monitor could not only save
lives, but save the quality of life for this vulnerable population. We propose to develop a small form-factor, on-
scene device capable of mapping the intracranial space and differentiating ischemic from hemorrhagic stroke.
During this program we will take the significant step of developing this technology with translation in mind
and demonstrating proof of feasibility in a pre-clinical human study of high-risk patients undergoing monitoring
after being admitted for stroke. We will develop a non-invasive sensing approach to intracranial monitoring (Aim
I), a key innovation for stroke use, and validate this sensing ability in a cohort of patients being monitored
following stroke (Aim II). By assessing the feasibility of our novel approach to non-invasive intracranial monitoring
in a tightly controlled patient cohort (post-stroke monitoring), we can validate our ability to 1) detect the presence
of stroke and 2) differentiate stroke type. This technology has the potential to not only aid in the clinic as a monitor
for detecting stroke onset within patients at high-risk for recurrent stroke or worsening status, but also in the field
for mobile stroke type discrimination. Because this system has a small form-factor, is non-invasive, is relatively
inexpensive (<$10k for an intracranial bioimpedance monitoring system), and is potentially able to discriminate
stroke type at first contact with the patient, this technology has the potential of being easily translated to and
accepted by the clinic for the benefit of diagnosing or tracking patients experiencing a stroke. We expect that by
the end of this program we will be in a position to optimize and miniaturize our technology and to conduct a larger
human study to demonstrate efficacy of our intracranial impedance monitoring technique.

Public health relevance
PROJECT NARRATIVE Stroke is the fifth leading cause of death in the US with more than 800,000 cases annually and over 140,000 deaths. With every 10-minute delay in treatment increasing long-term disability odds 11%, the identification and classification of stroke in-real time would be revolutionary for acute care. We have demonstrated that intracranial hemorrhage can be detected through use of electrical impedance sensing when invasive intracranial electrodes are used; here we aim to take the significant step of exploring non-invasive, yet translatable, approaches to mapping intracranial impedances for differentiating ischemic from hemorrhagic stroke as an in-clinic monitor, and then long-term in an emergency medical setting outside the clinic.